Targeting the PNP - SAMHD1 synthetic-lethal combination in cancer

Abstract
The enzymatic transition state structures of mammalian purine nucleoside phosphorylases
(PNPs) were solved experimentally in this laboratory by a combination of intrinsic kinetic isotope
effects (KIEs) and computational quantum chemistry. The resulting bond geometry and
electrostatic potential maps enabled the design and synthesis of transition state analogs.
Immucillin-H (aka BCX1777, Forodesine, Mundesine) inhibits human PNP with picomolar affinity.
The PNP blockade causes dGTP accumulation and apoptotic cell death specifically in activated
and malignant T cells. Forodesine entered clinical trials and was approved as an oral therapy for
refractory or relapsed peripheral T-cell lymphoma in Japan in 2017. Approximately 10% of
otherwise refractory patients treated with Forodesine therapy undergo complete remission.
Others show stable disease or no response. Genomic analysis of Forodesine responder vs non-
responder T-cells from cancer patients revealed drug efficacy inversely proportional to SAMHD1
expression (sterile alpha motif and HD-domain-containing protein 1). SAMHD1 is a dNTP
triphosphohydrolase (dNTP + H2O  dNuc + PPPi), preventing dGTP accululation from inducing
apoptosis in targeted cancer T cells. Therefore, the combination of SAMHD1 inhibitors with
Forodesine is expected to extend the therapeutic profile of human PNP inhibitors, a synthetic
lethal interaction.
Drug design by transition state analysis will be extended to SAMHD1, a rare triphosphohydrolase
activity. SAMHD1 inhibition has potential to enhance T-cell anticancer outcomes. The privilidged
enzyme-reactant geometry at the transtion state will be enlisted as one inhibitor design element.
Drug candidates designed to stablize the SAMHD1 protein geometry at the transition state will be
powerful inhibitors. Chemical screening with fragment libraries, some with covalent potential,
coupled by click chemistries, will be used in combinatorial inhibitor design as an alternative
approach. SAMHD1 inhibitors, used in combination with Forodesine, are expected to provide
improved therapeutic approaches to the spectrum of T-cell malignancies.
SAMHD1 docked to its transition state to define the enzymatic cavity at the transition state will be
used to grow complimentary, protein-stabilizing structures from library fragments to mimic the
transition state configuration. SAMHD1 conformational traps of transition state geometry will be
tight-binders. A Bronx-based novel patient-derived cancer T-cell library will be tested in culture
and in mouse xenografts with SAMHD1 inhibitors to explore the scope of synthetic lethal
interactions across genetically defined human T-cell cancers. The program will be achieved with
specific aims to: 1) solve the transition state structure of SAMHD1 from reactant and catalytic site
perspectives, 2) discover SAMHD1 inhibitors by conformational transition state stabilization,
fragment screening and growth into the catalytic site cavity, structural biology approaches and 3)
use cell culture and mouse xenografts to characterize the biological effects of this synthetic lethal
interaction.

Public health relevance
Public Health Relevance Statement Cancer therapy increasingly depends on the use of two or more drugs to complement and strengthen each others action. The approved cancer drug Forodesine is highly effective in cancers that are genetically missing a second cancer target called SAMHD1. But most cancers have excess SAMHD1 and there are no approved drugs or clinical trials yet reported for SAMHD1. Transition state analysis, featured here, has a proven record of generating powerful enzymatic inhibitors that have success in clinical trials. SAMHD1 inhibitor development has the potential to open a powerful therapeutic window for leukemia and other cancers.